Multi-cohort validation of machine learning radiogenomic models (ML-RGx) to predict late toxicity in prostate cancer

PROJECT SUMMARY
Radiotherapy is a cornerstone of treatment for prostate cancer, but radiation-related genitourinary (GU)
and gastrointestinal (GI) toxicities can negatively impact quality of life among survivors. Radiotherapy can
damage the bladder and rectum leading to gross bleeding, inflammation, pain, fibrosis, and when severe, life-
threatening complications. Up to 20% of men treated with radiotherapy for prostate cancer develop mild to
moderate late GU and/or GI toxicities that are often permanent and negatively impact quality of life; up to 5%
develop severe or life-threatening effects requiring medical or surgical intervention. Radiation exposure drives
risk of late toxicity, but genetic predisposition is a significant contributor and can explain why some patients
develop toxicity while others no not despite identical treatment plans. Our prior work shows that late GU and GI
toxicities are polygenic in etiology, with risk modified by the combined effects of many low-penetrance single
nucleotide polymorphisms (SNPs), raising the attractive possibility of using a polygenic risk score to identify
susceptible patients prior to starting radiotherapy. Towards this goal, we developed a novel machine learning
approach to combine information from many risk SNPs and dose-volume parameters into a radiogenomic (ML-
RGx) risk score. Our preliminary data shows that this modelling approach out-performs existing methods and
shows promise for use in the clinic. The proposed project will apply this method to a large training dataset from
the NCI-supported International Radiogenomics Consortium to build ML-RGx models of GU and GI toxicity that
will then be externally validated using data and biospecimens from two large phase III radiotherapy trials
completed through the NRG Oncology cooperative group. Bioinformatic approaches will be applied to prioritize
SNPs for inclusion in the modelling and to uncover biologic pathways underlying genetic predisposition to normal
tissue injury. The study has three aims: (1) to train ML-RGx models for each of radiation-induced GU and GI
toxicity and define a threshold for low and high risk; (2) to validate ML-RGx models in two independent datasets
from NRG Oncology cooperative group trials; and (3) to assess feasibility and impact of ML-RGx models on
treatment planning workflow in a Radiation Oncology clinic. This work will bring personalized medicine to the
field of radiation oncology and improve prostate cancer care. Our innovative modelling approaches will also
uncover important molecular pathways that could be targeted with interventions to prevent and/or mitigate
toxicities.

Public health relevance
NARRATIVE Prostate cancer impacts the lives of ~190,000 men diagnosed each year in the United States and, given the high 5-year relative survival rate of >95%, approaches to minimize treatment toxicities are needed. Bladder and rectal toxicities resulting from prostate cancer radiotherapy are dose-limiting, costly to the healthcare system, and negatively impact quality of life. This study will apply our novel machine learning method to develop and validate integrated dose-volume-genetic risk models for late bladder and rectal toxicity and assess feasibility of incorporating these models into clinical workflow as a critical step towards giving Radiation Oncologists the tools they need to personalize therapy and reduce toxicities.